Conditional male lethal Anopheles stephensi line for the efficient manufacture of malaria vaccines

Project Abstract
In 2020 malaria cases (241M) and deaths (627,000) reached the highest since 2012 emphasizing the urgent
need for new tools for prevention, control, and elimination of this disease. Sanaria’s Plasmodium falciparum
(Pf) sporozoite (SPZ) Vaccine, composed of radiation attenuated PfSPZ administered by intravenous injection,
assessed in 1740 subjects aged 5 months to 61 years in 6 countries in US, Europe and Africa, is safe and
protective for 18 months in Africa, while PfSPZ-CVac (chemo-attenuated) conferred 100% protection against
heterologous controlled human malaria infection for at least 12 weeks. PfSPZ are produced using aseptically
reared female Anopheles stephensi mosquitoes. Only females ingest blood, so in the current manufacturing
process, aseptic male mosquitoes are superfluous, consuming growth medium and occupy space that could
otherwise be used for production of more females at no additional cost or effort. In this project we plan to make
the aseptic mosquito rearing process 2-fold more efficient (reducing costs of vaccine manufacture by 10-15%)
by removing male mosquitoes from the system at the embryonic stage. This will be achieved by creating a
mosquito line in which males are conditionally expressing a lethal insect-specific hybrid toxin, originally
produced by spiders. The lethality will be induced on a switch, using the Tetracycline-controlled gene
expression system. In our specific aims we will: 1. Establish a driver line: a transgenic A. stephensi line
carrying the Tet-On transactivator (rtTA). A transgenic line will be created by inserting the rtTA, under the
tight control of the vasa promoter, which is expressed in the first few hours after egg laying. The construct will
be inserted using piggyBac-based germline modification. In the absence of doxycycline, rtTA should not bind to
the Tetracycline responsive element (TRE) and thus the lethal gene will be inactive when expression is not
wanted. 2. Establish a Y-linked docking A. stephensi line. We have identified specific Y-chromosome
genomic loci which can be used to target integration of the locus of X (lox) docking sites. RFP under the 3xP3
promoter, flanked by two lox sites will be introduced to the identified Y sequences using CRISPR-Cas9
mediated homology-derived repair. 3. Establish an effector line: A. stephensi carrying Y-linked spider
hybrid toxin under the control of the Tetracycline Response Element (TRE). The Y-linked docking line will
be used to integrate a gene cassette containing TRE, minimal promoter and the hybrid toxin via lox sites using
the cre/lox recombinase-mediated cassette exchange. In this transgenic line the lethal hybrid toxin will be
expressed only in male mosquitoes when both doxycycline and rtTA are available; in the absence of
doxycycline and rtTA no lethality is anticipated. 4. Generate a transgenic conditional male-lethal sexing
strain of A. stephensi. Females from the driver line will be crossed with males from the effector line. In the
progenitor male eggs, the rtTA will bind to TRE in the presence of doxycycline, driving the expression of the
toxin and induce male lethality, while in the absence of doxycycline both sexes will survive.

Public health relevance
PROJECT NARRATIVE Sanaria has developed highly effective Plasmodium falciparum sporozoite (PfSPZ) vaccines to protect individuals against malaria that are intended also for use in eradicating malaria from defined geographical areas; the first is a live attenuated whole organism vaccine called Sanaria® PfSPZ Vaccine, the second is a live infectious vaccine administered with an antimalarial drug, a vaccine called Sanaria® PfSPZ-CVac, and the third is a late arresting replication competent genetically attenuated vaccine, PfSPZ-LARC2. All these vaccines require the production of PfSPZ in aseptic female Anopheles stephensi mosquitoes. This proposal aims to increase the efficiency of aseptic mosquito rearing by genetically modifying mosquitoes such that immature male mosquitoes are killed by conditional expression of a lethal gene. Successful implementation of this project will reduce cost of vaccine manufacture by ~15%, thereby making the vaccine available at lower cost.